MAINTENANCE OF A NON-HUMAN PRIMATE BREEDING COLONY

Maintain a colony of non-human primates at a maximum level of 335 animals. Approximately 42 adult breeders and 40 immature females will be housed outdoors to replace breeders in the indoor program. The adult females housed indoors should provide approximately 80 pregnancies per year for investigator use plus replacement breeders to cover losses due to the colony as well as research generated mortality. Production of mature replacement females should be maintained ata level of plus or minus fifteen per year. This should ensure a self-sustaining colony.